Developmental Topology of the Human Cerebral Cortex

Project Summary/Abstract
A major long-term goal of this proposal is to understand human brain development and the origins of
neurodevelopmental diseases. The cerebral cortex is a structure where model systems, such as mouse or rat,
may not capture the complexity of architecture and function relevant for understanding human development and
disease. This proposal aims to address the gap in our understanding of human cortical development through the
study of primary tissue complemented by human stem cell-derived in vitro model systems, using ‘cerebral
organoids.’ Understanding human–specific aspects of brain development is not only critically important for
understanding the etiology of neurodevelopmental disorders, including autism and schizophrenia and ultimately
developing therapies, but will also benefit our understanding of human cortical evolution, the diversity and lineage
of neural cell types, and the mechanisms of cortical expansion - it will help define what makes us unique.
The developing human brain contains an enlarged proliferative region, the outer subventricular zone (OSVZ)
that is not present in rodents. This study will target two recently-discovered neural progenitor cell types found in
the OSVZ, outer radial glia (oRG) and intermediate progenitor (IP) cells. These cell types are particularly
important as they underlie the huge developmental and evolutionary expansion of the human brain. This proposal
seeks to illuminate the complexity of human cortical development in terms of the genomic, cellular, and
behavioral features of its constituent oRG and IP neural progenitor cells and their progeny through the key stages
of neurogenesis and gliogenesis. We plan to discover lineage trajectories that define progenitor-progeny
relationships and determine the cellular fates of clonal descendants. We will use novel oRG and IPC markers to
enrich progenitor cell populations for analysis, explore the signaling networks that regulate radial glia and IP cell
expansion and the molecular mechanisms defining neuronal and glial lineages and the underlying mechanisms
leading to the creation of cellular diversity. Additionally, we will explore the role of radial glia and intermediate
progenitors in diseases including focal cortical dysplasia and related neurodevelopmental diseases and pursue
an intriguing relationship between oRG cells and invasive glioblastoma.
These ambitious goals are attainable due to recent technological advances, including improvements in single
cell genomics, bioinformatics, and spatial transcriptomics, as well as in vitro models of human cortical
development. The outcome holds promise to transform our understanding of human brain development in health
and disease.

Public health relevance
Project Narrative This proposal seeks to discover how the neural stem and progenitor cells of the developing brain produce the large diversity of nerve cell types found in the human cerebral cortex. Developing therapeutic approaches to disorders of brain development ranging from major malformations to diseases such as autism and schizophrenia will require an understanding of the human-specific features of cortical development that are the subject of this study.